FOLLOW UP OF GESTATIONAL DIABETES MELLITUS IN HISPANICS

LAB: This is a follow-up study of Hispanic women who have had gestational diabetes mellitus. Insulin secretory profiles will be elevated in the baseline state and during glucose infusion in patients and controls.